Translating Intestinal Radioprotection by EGLN Inhibition to Improve Clinical Outcomes in Unresectable Pancreatic Cancer

Abstract Abstract not requested. This is an NCI Diversity Supplement to Dr. Cullen Taniguchi's Grant# 1R01CA227517-01A1, titled, Translating Intestinal Radioprotection by EGLN Inhibition to Improve Clinical Outcomes in Unresectable Pancreatic Cancer.

Public health relevance
Project Narrative Project Narrative is not requested. This is an NCI Diversity Supplement to Dr. Cullen Taniguchi's Grant# 1R01CA227517-01A1, titled, Translating Intestinal Radioprotection by EGLN Inhibition to Improve Clinical Outcomes in Unresectable Pancreatic Cancer.